The role of genetic and epigenetic variation in the progression of IDH mutant gliomas

Project Summary/Abstract
The candidate for this K22 NCI Transition Career Development Award is Dr. Jingyi Wu,
an Instructor in Pathology at Dana-Farber Cancer Institute, Harvard Medical School, and the
Broad Institute. This award focuses on Dr. Wu’s long-term objective of becoming an
independent investigator studying cancer epigenetics. Epigenetics is the fundamental
mechanism that enforces the transcriptional programs and drives cellular phenotypes.
Epigenetic regulation pathways are frequently altered in cancer, allowing transitions of cell
states to acquire various fitness advantages.
Building on Dr. Wu’s previous work, the enclosed application seeks to test the hypothesis that
epigenetic alterations render tumors the plasticity to switch cell states upon genetic variation
or drug treatment. The application presents preliminary data suggesting plasticity and cell state
switching during the progression of IDH mutant gliomas. It also identifies a candidate genetic
event and epigenetic perturbation that potentially drives cell state switching. The specific aims
of this application will 1) further confirm the role of genetic and epigenetic variation in cell state
switching and 2) identify the underlying mechanisms by which genetic and epigenetic variation
drive cell state switching. The results of the proposed studies should reveal new therapeutic
targets for IDH mutant gliomas.
The application will leverage cutting-edge single-cell genomics and epigenetic assays, as well
as advanced cell culture engineering and organoid disease models. This is a perfect extension
of Dr. Wu's published and ongoing work, where she developed new single-cell genomics tools
and applied them to other brain tumor models, including glioblastoma. Dr. Wu has access to
all the resources at DFCI, HMS and Broad Institute for developing her leadership to become
an independent investigator. She has also built a network for mentorship to ensure that she
can achieve her 3 long-term career goals 1) address important and fundamental questions in
cancer research, 2) mentor junior scientists, 3) build a collaborative community within the
cancer research field.

Public health relevance
Project Narrative The proposed research will identify the drivers that promote the progression of IDH mutant gliomas and provide candidate therapeutic targets for slowing down this process.